Columbia Roybal Center for Fearless Behavior Change - Renewal

The goal of the Columbia Roybal Center for Fearless Behavior Change is to advance behavioral interventions that reduce psychological distress and improve health behaviors in midlife and older adults that experience serious health events. Each year, millions of adults experience events such as heart attacks, strokes, or life-threatening cancer diagnoses. For some, these events serve as a wake-up calls, or “teachable moments,” and those patients acquire health behaviors that prevent recurrent events and slow disease progression. Yet, many of these patients are highly distressed after these events, leading to substantial impact on quality of life, health behaviors, and prognosis. For example, 1 in 3 patients develop PTSD symptoms after cardiac arrest and critical illness, and 1 in 5 patients develop persistent depressive symptoms after heart attacks. Those patients who are highly distressed are less likely to follow recommended health behaviors such as taking medications, exercising, and having good sleep. We have shown that many patients avoid medications because they are reminders of disease risk, and exercise because physiological changes (e.g., heart rate) are distressing reminders of the possibility of a recurrent event. Accordingly, our Roybal Center is interested in advancing interventions that target these fear-based mechanisms for which interventions are underdeveloped. There are already evidence-based interventions for reducing other common forms of psychological distress after serious health events such as anxiety and depression. Our Center also aims to conduct implementation research that accelerates the adoption of these effective interventions into practice.
Our Center will include a Behavioral Intervention Development Core that provides implementation science, regulatory, and statistical support to trialists. In the first year, this Core will launch a Stage II randomized clinical trial (N=90) testing a psychological intervention for PTSD (Acceptance and Mindfulness-Based Exposure Therapy) that was that was previously developed and feasibility tested by our Center versus a standard of care control (Present-Centered Therapy) in cardiac arrest survivors. This trial demonstrates our capacity to advance interventions through the NIH Stage Model within our Center. In the first year, our Center will also initiate a pragmatic cluster randomized trial (N= 50 clinicians; 200 patients) testing the effect of an implementation strategy (a digital patient activation tool) versus usual care on the uptake of evidence-based treaments for depressed patients with recent CVD events. This trial illustrates our Center’s capacity to conduct Stage V research. Our Center will also include an Administrative Core responsible for soliciting proposals for new trials consistent with our Center’s theme via a national competition. This Core will collaborate with NIA’s Stress Measurement Network and Science of Behavior Change program to ensure robust measurement of behavioral mechanisms in all trials. It will also oversee trials; disseminate findings; develop collaborations; and nurture the next generation of behavioral trialists.

Public health relevance
Most adults will experience serious health events in their lifetime, and these events will commonly result in psychological distress that impacts on quality of life and health behaviors that are needed to promote recovery and prevent recurrent events. Our Columbia Roybal Center for Fearless Behavior Change will advance mechanism-driven interventions that target psychological distress and assess whether better health behaviors result. Our existing research infrastructure inclusive of a common measures repository for mechanisms assessment, a standardized electronic assessment suite for behavior, implementation science expertise, and strong collaborations with patient stakeholders and scientific experts in the experimental medicine approach to behavioral intervention development will ensure that the trials conducted in our Center are well-positioned to yield impactful interventions.